Integration of a multi-pronged standardized methodology to identify key diseases and prioritized antimicrobial alternatives in production animals

PROJECT SUMMARY
Antimicrobial resistance (AMR) is recognized as a significant threat to the health of animals,
humans and plants, leading to calls to improve antimicrobial stewardship in all sectors. In order
to assure the best utilization of limited resources, there is a critical need to identify the
diseases and associated alternative strategies that, if implemented, would lead to the greatest
impact on improving antimicrobial stewardship. This proposal seeks to address this critical gap
with an approach that integrates evidence-based and decision-making methods such as
scoping reviews, structured expert elicitations (informed in some cases by proprietary large-
scale data and experience), and multi-criteria decision analysis (MCDA) across four livestock
groups. This approach provides a comprehensive, systematic, and transparent framework to
identify and prioritize the most important disease, and then the most promising alternative
approaches to reduce the use of medically important antimicrobials in food animals, while
maintaining animal health and wellbeing. The proposed project is significant in that, in contrast
to the present situation, successful completion of the project will generate comprehensive and
nuanced assessments of the disease drivers and recommendations on how to mitigate
antimicrobial use in chickens, beef cattle, dairy cattle and swine. This integrated methodology,
combined with application to four major food producing species, allows for a consistent and
innovative approach to addressing the specific needs outlined by FDA in this PAR. This effort
will be led by the National Institute of Antimicrobial Resistance Research and Education
(NIAMRRE), a member organization that fosters cross-sector engagement to combat the
challenges presented by AMR, in collaboration with RTI International, a nonprofit research
institute with expertise in scoping reviews, expert elicitation, and multi-criteria decision analysis.
NIAMRRE expertise includes investigators and subject matter experts from four major
agricultural research universities with deep expertise in animal health and livestock production:
University of California Davis (dairy cattle lead), The Ohio State University (beef cattle lead), the
University of Georgia (broiler chicken lead), and Iowa State University (swine lead). Collectively,
this team provides an outstanding environment for successful completion of the project. The
outcome of this framework is that a consistent approach will be applied across four major
livestock species, resulting in consistent communications of recommendations for strategies to
reduce reliance on medically important antimicrobials.

Public health relevance
PROJECT NARRATIVE This project will contribute to public health through developing recommendations for prioritized alternatives to antibiotics to manage diseases in major livestock species in order to reduce the use of antibiotics in food- producing animals. Bacteria that are resistant to antibiotics are a growing threat to public health and to food security and safety. Reducing antibiotic use in food-producing animals decreases the selection pressure for the emergence and spread of antimicrobial resistant bacteria in the environment and in areas where humans and animals interact, and supports antibiotic efficacy being preserved into the future.